TASK C33:Development of a Non-Human Primate Model of Zika Virus Infection for Product Evaluation

This contract provides for the development and standardization of non-human primate models for infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.